Capturing HSV entry glycoprotein complexes

PROJECT SUMMARY/ABSTRACT
Herpes simplex viruses (HSV-1 and HSV-2) infect most humans for life and cause skin sores, blindness,
encephalitis, developmental abnormalities, and disseminated disease. No vaccines are yet available, and current
therapeutics are non-curative. Therefore, there is an urgent need to develop new prophylactic and therapeutic
interventions. Being enveloped, HSV-1 and HSV-2 penetrate target host cells by fusing their lipid envelopes with
cellular membranes. This process requires several viral proteins – gD, gH, gL, and gB – each of which performs
distinct functions. This contrasts with most enveloped viruses, which combine all entry functions in one protein.
Such distribution of functions raises the question of how these proteins act, how they coordinate their activities
to ensure efficient membrane fusion and viral entry, and how best to target them for vaccine development. High-
resolution structures of the individual glycoproteins and stable complexes, such as gH/gL, have been
indispensable for guiding functional, mechanistic, and immunological studies. But little is known about how these
glycoproteins interact. High-resolution structural “snapshots” of glycoprotein complexes relevant to entry would
help answer many outstanding mechanistic questions, but complexes have been difficult to isolate, so no
structures of complexes (beyond that of gH/gL) are yet available. The current application proposes to apply new
methods to isolate HSV glycoprotein complexes and characterize their structures by cryoEM. Aim 1 will use
antibodies to stabilize gD/gH/gL complexes and characterize their structures. Aim 2 will use non-detergent
extraction methods to isolate HSV gH/gL/gB complexes and characterize their structures. The proposal will
leverage extensive experience in biochemical and structural studies of HSV glycoproteins as well as a newly
established cryoEM pipeline. A detailed structural and biochemical knowledge of how HSV glycoproteins interact
to facilitate cell entry will open new opportunities for rational vaccine and therapeutics design.

Public health relevance
PROJECT NARRATIVE Herpes simplex viruses (HSV-1 and HSV-2) infect most humans for life and cause a great disease burden, for which no vaccines or curative therapies are yet available. Unusually, HSV require four viral glycoproteins to penetrate host cells; here, we propose to develop strategies for isolating and characterizing their elusive complexes. A detailed structural and biochemical knowledge of how HSV entry glycoproteins interact to facilitate cell entry may open new opportunities for rational vaccine and therapeutics design.